Lipotoxicity in Alcoholic Liver Disease

? DESCRIPTION (provided by applicant): Alcoholic liver disease (ALD) is a leading cause of morbidity and mortality in the United States and worldwide. Unfortunately, there is currently no FDA approved medication for any stage of ALD. Advancing our knowledge on the pathophysiologic mechanisms of ALD will certainly pave the way to development of therapeutic interventions. Alcoholic steatosis is the earliest pathological change in the progression of ALD, and it is routinely assessed by histological and/or histochemical methods. However, these morphological methods can only demonstrate lipid droplets which contain neutral lipids with triglyceride as the major component. Although great efforts have been paid to understand the mechanisms by which alcohol abuse induces hepatic accumulation of lipid droplets, particularly triglyceride, increasing evidence suggest that free fatty acid (FFA) rather than triglyceride generates lipotoxicity. Accumulation of FFA in the liver has been documented in ALD, but the mechanisms of how alcohol abuse induces hepatic FFA accumulation and how FFA induces lipotoxicity have not been well defined. Lipid metabolism in the liver involves multiple metabolic pathways including de novo lipogenesis, fatty acid oxidation, lipid uptake and lipid export. In the past granting period, we have shown that alcohol abuse causes hepatic lipid accumulation by increasing fatty acid influx and reducing fatty acid oxidation as well as lipid export. White adipose tissue (WAT) as an energy buffering station communicates with liver by depositing liver-secreted triglyceride and releasing FFA to the liver. Alcohol impairs WAT functions in lipid storage and thereby leads to excessive FA release and hepatic influx. We found that lipin1, a critical enzyme in triglyceride synthesis, was dramatically reduced in the WAT after alcohol exposure, suggesting that lipid1 deficiency could be an important mechanism underlying alcohol-induced excessive FA release from the WAT to the liver. The hepatocytes control intracellular FFA level via two major mechanisms, assembling FFA into triglyceride and FA oxidation. Suppression of FA oxidation is likely an important mechanism underlying FFA accumulation in ALD. Accumulation of FFA in cells generates lipotoxicity. Our preliminary data showed that FFA induces ER stress and cell death dependent on activation of aryl hydrocarbon receptor (AhR). AhR is a xenobiotic nuclear factor, and activation of AhR is known to induce cell death. Our findings in the past granting period strongly support a novel concept that hepatic accumulation of FFA produces lipotoxicity via activating AhR signaling pathway. This project aims at understanding the mechanisms of how chronic alcohol exposure induces hepatic accumulation of FFA and how FFA induces cytotoxic signaling in the liver. Our overall hypothesis is that increased hepatic FA influx and impaired FA clearance account for alcohol-induced hepatic accumulation of FFA, and activation of AhR signaling pathway by FFA represents a novel mechanism underlying FFA lipotoxicity.

Public health relevance
PUBLIC HEALTH RELEVANCE: Alcoholic liver disease is a leading cause of morbidity and mortality worldwide, but effective therapies are currently lack. This project is to investigate the mechanisms of how alcohol abuse induces hepatic accumulation of free fatty acid and how free fatty acid causes cell death. The goal of this project is to explore molecular targets for development of therapeutic interventions.